Tissue-specific functional genomics in the acute respiratory distress syndrome

PROJECT SUMMARY
The acute respiratory distress syndrome (ARDS) affects more than 200,000 adults each year in the United
States and carries a high mortality risk. Heterogeneity in susceptibility and outcomes are prominent features of
ARDS, and improved understanding of the genetic underpinnings of ARDS would advance our ability to define
ARDS subphenotypes, predict disease risk, and identify new therapeutic targets: a critical challenge identified
in the NHLBI’s most recent Strategic Vision plan. This K01 proposal will provide Dr. V. Eric Kerchberger, MD
with critical training for his long-term career goal of bringing precision medicine to critical care by applying his
expertise in biomedical informatics and genetic analysis to leverage the power of large-scale electronic health
record (EHR) databases and DNA biobanks. The project will be completed under the guidance of primary
mentor Lorraine B. Ware, MD and co-mentor Wei-Qi Wei, MD, PhD, and a research advisory committee of
experts in precision medicine, biomedical informatics, and functional genomics. By integrating existing GWAS-
level genotyping with PrediXcan, an advanced functional genomics framework, this project will quantify tissue-
specific gene expression levels for lung tissue and immune cells in 3,100 critically ill adults enrolled in the
Validating Acute Lung Injury Markers for Diagnosis (VALID) Study cohort. Then, leveraging Dr. Kerchberger’s
expertise in EHR phenotyping, we will validate the genetic findings from VALID in an independent sample of
ARDS patients from BioVU, Vanderbilt University Medical Center’s large de-identified DNA biobank. This
mentored research project has three specific aims: Aim 1: Test the association between genetic regulation of
gene expression and ARDS susceptibility in at-risk adults. Aim 2: Test the association between genetic
regulation of gene expression and patient-centered outcomes in ARDS. Aim 3: Use advanced phenotyping
methods to identify ARDS patients and at-risk controls in BioVU, and replicate gene expression associations
identified in VALID.
Completion of these studies will yield novel methods to identify ARDS patients and at-risk controls from large
EHR databases, and advance our understanding of tissue-specific gene expression in ARDS, bridging the gap
between genetics and biology. The knowledge gained from this proposal will provide vital preliminary data for
Dr. Kerchberger to design and execute future R01 proposals to study functional genomics in ARDS using NIH-
supported EHR biobanks such as the Electronic Medical Records and Genomics Network and the NIH All of
Us Project. Furthermore, Dr. Kerchberger will gain new skills in the clinical translation of functional genomics
and advanced EHR phenotyping, forming the foundation for Dr. Kerchberger to independently lead
collaborative teams of clinicians, geneticists, and data scientists to conduct large EHR-based studies of critical
illness syndromes that will improve risk prediction, identify novel disease subtypes using genetic risk, and
ultimately bring precision medicine to the critically ill patient.

Public health relevance
PROJECT NARRATIVE Genetic differences between individuals can influence gene expression levels across different tissues and cell types, and it is unknown if this tissue-specific regulation of gene expression affects risk of developing the acute respiratory distress syndrome (ARDS) during critical illness. In this proposal, we will apply an advanced computational framework to existing genetic data to predict the gene expression levels of lung tissue and immune cells in patients at high risk for developing ARDS. This research will advance practitioners’ ability to incorporate genetic information to bring more personalized care to critically ill patients.